MIGRATION OF NEURAL CREST CELLS INTO CRANIFACIAL COMPLEX

Research will involve the craniofacial development stemming from the migrati of neural crest cells into the craniofacial complex and the mechanisms by which this occurs.